AGING AND INTESTINAL RESISTANCE TO 1,25 (OH) 2D ACTION

The purpose of this study is to test if the intestinal resistance to the hormone 1,25(OH)2D that is associated with the aging process and impaired calcium absorption is due to a decrease in vitamin D receptor levels in the intestine or to a postreceptor defect or to both. The study was completed in 1998 and analysis is ongoing.